Craniofacial cartilage differentiation from human neural crest stem cells in 3D cultures

Craniofacial cartilage differentiation from human neural crest stem cells in 3D cultures
Birth defects and injuries to the head and face require surgical reconstruction and
rehabilitation. It is difficult to reconstruct cartilaginous features (nose, ears) with plastic
surgery techniques, and transplanted tissue is often rejected without
immunosuppressants. The ability to make bona fide craniofacial cartilage – cartilage of
the head and face – from patient-derived induced-pluripotent stem (iPS) cells to repair
these birth defects and injuries has tremendous translational applications, but is not yet
possible because we don't know enough about the mechanisms of differentiation that
form this tissue in human beings. Using stem cells is the key to understanding human-
specific cell signaling mechanisms that drive differentiation of craniofacial chondrocytes,
the cells that make cartilage. We have grown craniofacial cartilage organoids from
human neural crest stem cells (NCSCs) derived from embryonic stem cells (hESCs)
and induced-pluripotent stem cells (iPSCs). We have initiated detailed characterization
of gene expression at the RNA and protein level in these organoids with an eye towards
generating specific hypotheses about mechanisms of differentiation that may be
manipulated for recellularization of damaged or defective craniofacial cartilage. Our
strategy involves seeding cells in three dimensional (3D) matrices (hydrogels) together
with extracellular matrix (ECM) components that we have identified in organoids. We
focus on cells cultured in 3D scaffolds because we hypothesize that craniofacial
cartilage generation will be more rapid and reproducible in 3D constructed organoids
than in self-organizing organoids. We hypothesize that, in addition to being components
of the structurally resilient matrix that defines cartilage, the ECM components that we
identified play a profound cell signaling role in chondrocyte differentiation. A second
strategy is to target cell signaling pathways that are hypothesized to play a role in
specifying chondrocyte cell fate. We have identified a number of growth factors and
their receptors in two populations of cells that generate cartilage, mesenchyme cells
and nascent chondrocytes. We hypothesize that adding these growth factors will
activate cell signaling pathways to make cartilage differentiation more rapid and
reproducible in 3D cultures. This project will combine NCSC differentiation with 3D
bioprinting with an eye towards scaling up to grow functional, transplantable craniofacial
cartilage in the lab. These studies will considerably advance an innovative approach to
tissue engineering towards the long-term goal of building a nose, ear, or other
cartilaginous structures of the head and face using human stem cells.

Public health relevance
The proposed studies will investigate tissue regeneration of functional craniofacial cartilage for transplantation. Neural crest-derived craniofacial cartilage will be created from stem cells in three dimensional cultures with an eye towards regrowth of the cartilaginous structures of the face such as the nose and ears. Our studies also have relevance for understanding craniofacial birth defects and cancers derived from the neural crest.